Access to National Death Index (NDI) Vital Statistics Data

Agreement for NIA to purchase access to the National Death Index, a centralized database of death record information managed by the CDC National Center for Health Statistics